INFECTIOUS COMPLICATIONS OF MALIGNANCY AND HIV INFECTION IN CHILDREN

Our studies are devoted to developing methods to define cancer patients who are at risk for developing serious infection, to improving the ability to diagnose these infections early, to treat hem effectively, and ultimately to prevent them. We are developing new therapeutic approaches based on the ability of new antibiotics particularly the beta-lactams and the quinolones. We have shown that certain beta-lactams used as single agents can replace the need for combination antibiotic therapy. Our studies are also defining die antibiotic therapy for documented infections, particularly the role of oral antibiotic therapy; the necessary duration of empiric therapy or patients with unexplained fevers and the choice of empiric antifungal therapy. We have developed a unique model for studying die pathophysiology, natural history, treatment and prevention of invasive candidiasis in the neutropenic host. This model permits the evaluating of new antifungal agents as well as immunoregulatory agents. To prevent infections we are valuating the role of passive immunization with a pooled immunoglobulin preparation that contains activity against the enterobacteriaceae as well as die pseudomonads. We are also studying), other immunoregulatory agents that may serve as adjuncts to the treatment of infection, including interleukin 1 and 2, GM-CSF and M-CSF. Wi have developed a program to evaluate the benefits of antiretroviral agents in children with HIV infection. To date, these have focused on sniffles with dideoxynucleosides. Studies with immunoregulatory agents and with biologicals (e.g., rCD4) are also underway.